Data Resource Core

PROJECT SUMMARY
The Kids First Data Resource Core (DRC) provides the community facing portal, cloud-based workspace
(CAVATICA), and analytic tools that support analysis and scientific discovery utilizing Kids First Data as
provisioned by the Kids First Data Coordinating Core (DCC). The aims of this project expand and improve upon
the existing Kids First Data Portal Core to provide a wider scope of data resources to the community to support
analysis and scientific discovery. The Kids First Portal provides researchers, clinicians, data scientists, patients,
and their family members with a fully functional database to explore, build virtual cohorts, and analyze clinical
and genomic data. As part of this project, the portal will be expanded to include advanced cohort building and
search capabilities, including genes and variants as well as new analytic capabilities. The portal and CAVATICA
will have new integrations, such as the variant workbench and deployment of lightweight scientific applications
to better empower a wide range of users. The DRC will also work towards understanding new and emerging
opportunities to support artificial intelligence and machine learning (AI/ML) techniques and workflows. To enable
the broadest use of Kids First data, the DRC is committed to interoperability and will leverage standards such as
GA4GH DRS, NIH Research Auth Service, Common Workflow Language, FHIR and other emerging standards
across the NIH data landscape.